Development of Distinct Areas in the Human Cerebral Cortex

PROJECT SUMMARY
The objective of this proposal is to gain a deeper understanding of the genetic programs that give rise
to the development of specialized areas within the human cerebral cortex. Abnormalities in cortical
development can lead to a wide range of neurodevelopmental disorders, which often affect different cortical
areas differently. Despite of its significance, the process by which specialized areas develop remains poorly
understood. This proposal aims to address this gap of knowledge by studying primary tissue and human stem
cell-derived brain organoids. The first aspect of the research will utilize spatially resolved transcriptome
analysis to examine human fetal cortex samples from multiple areas and embryonic ages, to identify the genes
that are involved in area-specific neuronal fate specification. The second part will focus on developing the
method for inducing areal identities in human brain organoids by pharmacological manipulation of signaling
pathways, serving as a model for how morphogens induce area-specific cell fates in vivo. The proposed aims
are attainable due to the strong background of the candidate and supportive environment provided by the
mentor’s laboratory and the institution. The anticipated outcome of this research will be new insights into the
principles of human cortical development, which could shed light on the etiology of neurodevelopmental
disorders and ultimately transform our understanding of cortical development in health and disease.
The candidate’s career goal is to become an independent researcher in an academic institution, leading
a research program that utilizes human stem cell models and neurogenetics approaches to study
neurodevelopmental disorders. The candidate’s prior research in the development and application of organoids
as model for human brain development and diseases sets a strong foundation. The proposal outlines a
comprehensive plan for scientific and professional growth that encompasses hands-on training, didactics, and
mentorship. Key scientific training goals include acquiring expertise in single-cell bioinformatics, spatial
transcriptomics, disease genetics analysis, and conducting rigorous optimization of organoid protocols.
Additionally, the candidate will engage in structured trainings in career development to facilitate independence.
The candidate will be mentored by Dr. Christopher Walsh, a renowned neuroscientist who has mentored
dozens of successful independent investigators. The candidate will also benefit from the support of an advisory
committee with complementary expertise. The mentored phase of the proposal will take place in the laboratory
of Dr. Walsh at Boston Children’s Hospital and Harvard Medical School, known for providing exceptional
research and training environments. The proposed training and research will provide the candidate with the
necessary resources and support to establish a thriving independent research program.

Public health relevance
PROJECT NARRATIVE The proposed research seeks to gain a deeper understanding of the genetic programs that regulate the development of specialized areas within the human cerebral cortex. Abnormalities in this process can result in neurodevelopmental disorders including autism spectrum disorder, epilepsy, intellectual disability, and neuropsychiatric diseases. By exploring the mechanisms behind the development of distinct cortical areas, this research has the potential to provide valuable insights into the causes of these disorders and inform the development of new treatments.